CIDR: GENOTYPING SERVICES USING GWAS ILLUMINA H3AFRICA ARRAY FOR NINDS (OWOLABI)

Stroke is the second leading cause of death globally. Ischemic stroke which accounts for up to 90% of strokes in the USA, is the clinical culmination of several complex and interacting biological processes, initiated by
various genetic and environmental factors, thereby making ready analyses of its underlying mechanisms challenging. A substantial amount of genetic risk for stroke remains unexplained. Moreover, genetic variants
previously associated with stroke in African and European Americans could not be translated into clinical use because they have not been validated and functionally annotated. A better understanding of these unique
factors is imperative for the formation of successful tailor-made interventions to mitigate this colossal burden. Due to its higher stroke heritability and resolution for fine mapping, the continental African population holds the aces to advancing stroke genomics but has never been included in stroke GWAS studies. The overall goal of SIBS-Genomics is to discover, replicate and functionally characterize novel genetic variants associated with ischemic stroke in people of African ancestry. SIBS Genomics will leverage several NIH-funded initiatives in the US and Africa led by SIBS Genomics investigators including the Stroke Investigative Research and
Educational Network (SIREN U54HG007479), the largest study of stroke in people of African ancestry. Indeed SIBS Genomics promises to substantially advance the global effort to discover the novel genetic loci for ischemic stroke thereby facilitating the understanding of the corresponding molecular mechanisms of ischemic stroke for several reasons: a) use of accurately phenotyped subjects with comprehensive covariate dataset
(special stroke phenotyping software with patent developed in SIREN), b) use of a novel NIH-funded most effective chip for dense genome-wide association study in African ancestry, c) an unexplored population with
substantially higher heritability and racial predilection of stroke; and higher resolution for fine-mapping due to its low linkage disequilibrium.

Public health relevance
Ischemic stroke is still a leading cause of death, disability, and dementia in the USA, especially among people of African ancestry. To tame this huge burden, a complete understanding of its risk factors is inevitable for developing targeted prevention strategies and other interventions. SIBS Genomics will culminate in a better understanding of the genetic and environmental contributions to stroke thereby contributing to the development of new solutions to control its burden and reduce deaths, disability, and dementia in the USA and beyond.